Quantifying Uncertainty to Inform Time-Limited Trials of Invasive Mechanical Ventilation

PROJECT SUMMARY/ABSTRACT
About 800,000 patients with acute respiratory failure are initiated on invasive mechanical ventilation (IMV) in
the United States annually; however; over 1 in 10 patients are subsequently unable to be liberated from IMV
and progress to prolonged IMV. Progression to prolonged IMV is viewed by many patients as a state worse
than death, but may occur by default (even if inconsistent with the patient’s stated goals) due to a combination
of clinical momentum, missed opportunities for shared decision-making, and prognostic uncertainty. Time-
limited trials (TLTs) are a promising model of care that directly address each of the barriers to goal-concordant
care and can facilitate earlier, more informed shared decision-making. A TLT is a collaborative plan
among clinicians and a patient/family to try life-sustaining therapy for a defined duration, after which the
patient’s clinical course informs prognostication and guides subsequent decisions.
The American Thoracic Society has recently identified major knowledge gaps hindering implementation of
TLTs. First, clinicians’ ability to accurately recognize prognostic uncertainty is limited, leading to risk of bias
and underuse of TLTs. Second, the optimal duration of TLTs for IMV remains undefined. Suggested TLT
durations range widely from 1-7 days, indicating a substantial knowledge gap in setting optimal TLT durations.
Third, while clinicians have requested empirical guidance to inform patient selection and duration of TLTs, how
clinicians will incorporate this guidance into the complex, dynamic context of critical illness is unknown. We
propose to fill these critical knowledge gaps through a novel approach. Using a large, granular database
including ~25% of US hospitalizations, we will (1) identify patients with greatest uncertainty in prognostic
estimates at the time of IMV initiation to inform TLT patient selection, (2) characterize the temporal profile of
uncertainty during the course of IMV to inform a patient’s TLT duration (by defining the point at which
prognostic gains plateau with each passing day), and (3) assess the thresholds of uncertainty that affect
clinician decision-making. This proposal is in direct response to NHLBI’s Notice of Special Interest in Palliative
Care (NOT-HL-23-117), by seeking to facilitate earlier shared decision-making, develop clinical tools that can
inform optimal timing and discussions on palliative care, and evaluate the factors influencing adoption and
penetration of a TLT clinical tool. Results will synergize with ongoing studies of patient-centered outcomes of
TLT and directly inform future clinical trials implementing an improved TLT framework to improve delivery of
quality, goal-concordant care to patients with acute respiratory failure.

Public health relevance
PROJECT NARRATIVE As a result of clinical momentum, missed opportunities for shared decision-making, and prognostic uncertainty, patients receiving invasive mechanical ventilation often progress by default to long-term mechanical ventilation through a tracheostomy – a state viewed by many as “worse than death.” Time-limited trials (a collaborative plan between clinicians and patients/surrogates to trial life-sustaining therapy for a pre-defined duration) are a model of care that can directly address the above barriers to goal-concordant care, but many knowledge gaps hinder operationalization of time-limited trials. We propose to fill these critical knowledge gaps – including optimal patient selection for time-limited trials, optimal time-limited trial duration, and the thresholds at which clinicians would initiate and end time-limited trials – through a novel approach that not only estimates prognoses but quantifies prognostic uncertainty and its impact on physicians’ decision-making.